Determining the efficacy and protective mechanism of a bivalent Chlamydia vaccine

The proposed study focuses on developing a novel bivalent vaccine to combat Chlamydia
trachomatis (CT), a leading sexually transmitted bacterial infection which can spread to the upper
genital tract of women and cause pelvic inflammatory disease, infertility, and chronic pelvic pain.
No FDA-approved vaccine exists for CT, and due to its largely asymptomatic nature, many
infections go undetected and untreated, increasing prevalence and risk for sequelae. This project
builds on promising preliminary findings using a vaccine formulation combining Chlamydial
Protease Activity Factor (CPAF), a conserved and immunodominant antigen, with a Stimulator of
Interferon Genes (STING) agonist, ADU-S100, in murine models. This vaccine elicited robust CD4
T cell responses and significantly reduced bacterial burden but fell short in preventing oviduct
pathology. To enhance efficacy, the study proposes a bivalent vaccine incorporating CPAF and
the chlamydial Major Outer Membrane Protein (MOMP), a key target for opsonizing antibodies,
conjugated with a novel STING agonist (CL1151) via click-chemistry. The central hypothesis
posits that the bivalent vaccine will generate synergistic Th1 immunity and antibody responses
critical for reducing bacterial load and preventing pathology. Specific aims include: (1)
Determining whether a bivalent CL1151-conjugated vaccine improves protection over monovalent
CPAF-CL1151, and elucidating the contribution of CD4 T cells and opsonizing antibody to
protection. (2) Determine the downstream molecular mechanisms induced by the STING
adjuvant, CL1151, in protection, including assessment of the roles of TNFα and type I interferon
signaling. Experimental methods involve priming and boosting mice with various vaccine
formulations, monitoring bacterial burden, and evaluating immunological responses via ELISpot
and intracellular cytokine assays. Additional studies will investigate protective mechanisms
through adoptive transfer experiments and gene knockout mouse models. Findings aim to clarify
mechanisms of vaccine-induced immunity and establish a foundation for advancing a protective
CT vaccine. This work addresses critical gaps in CT vaccine development and holds potential to
mitigate the global burden of chlamydial infections.

Public health relevance
PROJECT NARRATIVE Chlamydia trachomatis is the most common sexually transmitted bacterial infection globally, and in women, the infection can ascend from the cervix to the upper genital tract and cause pelvic inflammatory disease that may lead to pelvic pain, infertility, and ectopic pregnancy. The objective of this proposal is to determine vaccine- induced requirements for protection from bacterial burden and oviduct pathology in a female murine model of Chlamydia genital infection. The research outlined in this proposal will inform rational vaccine design, to combat the ongoing Chlamydia epidemic and associated complications.